Family-based methods to analyze sequence data to elucidate AD etiology

SUMMARY/ABSTRACT Whole genome and exome sequence data is currently being generated for population-­ and family-­based studies to elucidate the involvement of rare variants in the etiology of complex traits including on Alzheimer’s Disease (AD). Although many rare variant population-­based association methods have been developed there are extremely few methods to study families. Analyzing families to detect complex trait associations can be advantageous because susceptibility variants that segregate in families can have larger effect sizes than those found in sporadic cases, thereby increasing the power for detection, while avoiding spurious findings due to population substructure and admixture, that can plague rare variant population-­based studies. For rare variant complex trait analysis, we will develop family-­based association and linkage methods. Rare variant mixed model association methods will also be developed for analysis of related and unrelated individuals. All developed methods will be used to study late-­onset AD;? analyzing whole genome and exome sequence data generated on families, cases and controls to discover novel genes and elucidate mechanisms underlying AD. AD status, as well as quantitative traits age of onset, memory and memory decline will be analyzed. The developed methods will be implemented in our SEQSpark software to allow for rapid analysis through parallel processing. Completion of this study will develop methods and software to elucidate complex trait etiology. Application of these methods, analyzing existing AD sequence data from the Alzheimer’s Disease Sequencing Project (ADSP) and the National Institute of Aging Late-­onset Alzheimer’s Disease (NIALOAD) study, will elucidate a better understanding of late-­ onset AD etiology and risk factors. Identifying susceptibility variants for AD is the first step in risk prediction and development of treatments with high efficacy. This study has high public health significance, since late-­onset AD causes considerable morbidity within the elderly and AD prevalence is increasing due to an aging population.

Public health relevance
Novel methods will be developed to perform rare variant linkage and association analyses of binary and quantitative traits for families and population data. The developed methods will be used to analyze late- onset Alzheimer’s Disease families, cases and controls from the Alzheimer’s Disease Sequencing Project (ADSP) and the National Institute of Aging Late- onset Alzheimer’s Disease (NIALOAD) study. This study will bring about a deeper understanding of the genetic etiology of late- onset Alzheimer’s Disease.